Defining the molecular connections between hyperexcitability and neurodegeneration in ALS

ALS is a rapidly progressive and fatal disease of the motor nervous system. Motor neuron hyperexcitability,
manifested as muscle fasciculations and captured in clinical neurophysiological tests1–3, is an early
pathological feature that affects both the 10% of familial ALS (fALS) patients who harbor dominant mutations in
one of over 25 ALS genes, and the 90% of apparently sporadic ALS (sALS) patients who do not have an
affected family member4. However, we do not know whether hyperexcitability causes motor neuron
degeneration. Mouse, invertebrate, and human induced pluripotent stem cell (iPSC) models have all shown
abnormal motor neuron excitability5–8. However, the mechanistic connection between hyperexcitability and
motor neuron degeneration remains unclear6,9,10.
In this proposal, we will use iPSCs from fALS patients to derive motor neurons and test the link between
hyperexcitability and motor neuron degeneration. We will determine whether multiple fALS mutations increase
motor neuron excitability, whether hyperexcitability precedes neurite retraction and cellular stress, and whether
hyperexcitability can cause neurite retraction, cellular stress, and motor neuron death. Furthermore, we will
examine transcriptomic signatures of multiple fALS lines before, during, and after motor neuron neurite
retraction. We anticipate that ion channel transcripts, as identified by gene ontology, will precede neurite
retraction in support of an excitotoxicity model. We will then determine whether potential ion channel transcript
changes are directly responsible for increased excitability using patch electrophysiology. Finally, using the
intersection of RNA-sequencing data sets, we will determine whether RNA-seq signatures from iPSC derived
motor neurons overlap with sporadic ALS patient spinal cord tissue.
The proposed project is feasible within the three-year time frame because of our experience with high-yield
motor neuron differentiation protocols, gene editing, high-content imaging technology, electrophysiology, and
computational analyses. The proposed work will determine whether there is a causative link within multiple
fALS genetic subgroups between hyperexcitability, and motor neuron degeneration. The project results will
have a direct impact on clinical trials attempting to normalize motor neuron excitability in patients. Furthermore,
the transcriptomic signatures of multiple fALS lines before, during, and after neurite retraction will allow us to
identify common features of motor neuron neurodegeneration that may also apply to sALS, and thus have
larger therapeutic implications. Finally, our access to patient tissue allows us to validate specific findings
related to excitability and transcriptomic signatures to determine their clinical relevance. We anticipate that this
proposal will determine whether hyperexcitability is caused by fALS mutations and contributes to
neurodegeneration in ALS, directly impacting ongoing clinical trials and therapeutic development.

Public health relevance
Patients with both familial and sporadic amyotrophic lateral sclerosis (ALS) show pathological motor neuron hyperexcitability. In this study, we will test whether motor neurons from familial ALS patient stem cells also display hyperexcitability, whether reducing hyperexcitability mitigates other cellular disease phenotypes, and whether transcriptional dysregulation of specific ion channels causes the excitability imbalance. Our project willhelp resolve the link between hyperexcitability and neurodegeneration, directly impacting current clinical trials and therapeutic development.